Neural regulation of susceptibility to hyperarousal

Since 2001 nearly 2 million US troops have served in the wars in Afghanistan or Iraq. Common to these
hostile environments, exposure to a traumatic stress can lead to post traumatic stress disorder (PTSD). As a
result, up to 31% of soldiers suffer from PTSD at some point in their lives. In addition to the debilitating
consequences on mental health, PTSD also increases the risk of developing cardiovascular disease. A cardinal
feature of PTSD is elevated sympathetic nervous system activity (ie., increased norepinephrine, NE) that is
thought to contribute to both the psychiatric symptoms of PTSD and increased risk of cardiovascular disease. In
the brain, the locus coeruleus (LC) is the major source of NE, a brain region capable of promoting the behavioral
and cardiovascular abnormalities that define PTSD. Therefore, therapies that reduce LC activity, and thus
suppress NE release are attractive targets to treat PTSD with comorbid cardiovascular disease. IL-1b
accumulates in specific brain regions in stress susceptible individuals and serves to promote LC-NE
hyperactivity. We have identified that when rats are confined in a protected region of an aggressive resident’s
cage, forced to witness a social trauma in the form of social defeat between two males, it generates long lasting
indices of behavioral and autonomic hypervigilance. By conducting this study in males and females, this allows
for a parallel understanding of how the LC regulates hypervigilance in both sexes and fulfills a critical gap in
knowledge in PTSD pathology. The overarching goal of the proposed research project is to use this animal model
of combat-related trauma to identify druggable targets that can suppress neural regulation of hyperarousal. We
propose that stress-induced adaptations of IL-1b in the LC initiate the cascade that promotes LC-NE hyperactivity
and resulting susceptibly in two ways. 1) IL-1b is chronically upregulated in the LC of witness stress-exposed
rats, which directly functions to stimulate LC-NE neurons. 2) IL-1b promotes accumulation of ROS (i.e.,
superoxide) which, in the LC disengages a major inhibitory input via downregulation of µ-opioid receptors (MOR).
Thus, this stress-sensitive LC-NE response is poised to promote the pathophysiological mechanisms underlying
LC-NE hyperarousal. The following specific aims will utilize integrative, translational and cutting-edge techniques
to test the hypothesis that a combined effect of IL-1b and ROS regulate LC-NE hyperactivity that is central
to promoting trauma-induced behavioral and autonomic dysfunction in males and females To achieve
these goals, rats will be treated with intra-LC vehicle, IL-1 receptor antagonist (IL-1ra), n-acetylcysteine (NAC,
an antioxidant) or a combination of the two. The specific role of these treatments to block behavioral and
autonomic indices of hyperarousal will be determined (Aim 1) and the molecular mechanisms modified by these
treatments will be identified in unstressed controls and stressed male and female rats in addition, postmortem
LC tissue from the VA Brain Bank will also be evaluated (Aim 2). Furthermore, Aim 3 tests the therapeutic
capability of intracerebroventricular IL-1ra and NAC administration to reverse the hypervigilant phenotype in
order to achieve two major goals: 1) To confirm that the locus of efficacy for the therapeutic effects of anti-
inflammatory and anti-oxidant therapy is the LC and 2) to measure cardiovascular telemetry with simultaneous
LC electrophysiology in awake behaving animals, demonstrating for the first time the covariance between LC
neuronal firing and sympathovagal balance in males and females with a hypervigilant phenotype. The proposed
studies are significant because understanding neural mechanisms of susceptibility to hypervigilance will lead to
preventative and therapeutic treatments capable of directly enhancing the lives of our veterans. Moreover, this
work has the immense potential to help identify preclinical screening of FDA-approved interventions that could
be repurposed to treat PTSD hyperarousal in humans and rapidly translated into our veteran population.

Public health relevance
Project Narrative Exposure to traumatic stress, as is common during combat, can lead to post traumatic stress disorder (PTSD) in susceptible individuals. As such, the lifetime prevalence of PTSD in combat soldiers is 6-30%. In addition to the debilitating consequences on mental health, PTSD is associated with an increased risk of developing cardiovascular disease. Abnormal increases in the fight-or-flight neurotransmitter, norepinephrine, are thought to contribute to the development of hyperarousal, a major symptom of PTSD and facilitator of cardiovascular disease. The overarching goal of our research is to use an animal model of combat-related trauma to identify druggable targets that can improve regulation of hyperarousal. Specifically, these studies will test the hypothesis that an inflammatory molecule signaling within the locus coeruleus, a stress-sensitive brain region, promotes trauma-induced behavioral and cardiovascular risk in males and females.